B-1 cells, IgM and Protective Humoral Immunity to Influenza

Influenza A and B virus infections induce robust innate and adaptive immune responses in the healthy
human population, a response that is recapitulated with various animal models, including mice. Although
these responses do not usually result in sterilizing, broadly reactive (heterosubtypic) immunity that protects
from infection with all influenza strains, they do strongly reduce mortality rates and disease severity
following heterosubtypic infections. A non-redundant component of this robust response is the production
of “natural IgM”, spontaneously-produced antibodies that bind broadly to all test influenza virus strains.
Natural IgM is produced in the steady-state by classical B-1 cells and by terminally-differentiated B-1-
derived plasma cells in spleen and bone marrow and following influenza infection also in the draining lymph
nodes by CD5+ B-1 cells mobilized from the pleural cavity. In their absence, or in the absence of the Fc-
receptor for IgM (FcµR) on B cells, fully protective humoral immunity is not established, mice show
increased lung viral loads, and they succumb to infection at increased rates. Thus, natural IgM and the
cells responsible for their production are part of the “broadly protective” immunity to influenza, a complex
and diverse response that significantly reduces disease burden and death among those infected.
Elucidating what constitutes the most effective, mortality and morbidity-reducing, broad immunity to
influenza is of high significance for the design of new therapeutic and prophylactic treatments, and is the
long-term objective of this proposal. It is therefore responsive to PA-18-859, which aims to support
research dedicated to the development of a universal influenza virus vaccine. Specific Aim 1 Is to
determine the signals required for the terminal differentiation of B-1 cells to strongly IgM-secreting plasma
cells (B-1PC). Using in vivo cell depletion and cell reconstitution experiments we will identify the signals
required for B-1PC development. Gene expression and functional studies will determine the repertoires
and anti-influenza activity of natural IgM from B-1PC and B-1 cells, respectively. Specific Aim 2 will
investigate the effects of TLR and BCR-mediated signals on B-1 cell responses to influenza. We will test
our hypothesis that a two-step process activates CD5+ B-1 cells: TLR-mediated signals induce cell
proliferation and loss of the BCR signaling inhibitor CD5, enabling subsequent BCR-signals to drive
specific B-1 cell responses. Finally, in Specific Aim 3 we will explore the mechanism underlying the non-
redundant function of secreted IgM and of the FcµR in enhancing protective T-dependent IgG responses
to influenza in vitro and in vivo. Expected results would provide conceptional advances for understanding
natural IgM, CD5+ and CD5- B-1 cell function, and the fundamental processes underlying T-dependent B
cell activation. The data would identify natural IgM as a critical prophylactic target for enhanced broad
humoral immunity to influenza.

Public health relevance
Narrative Strong immune responses following a natural infection with influenza activate a small subset of antibody- secreting cells, whose broad reactive antibodies can bind all tested strains of influenza virus. This grant proposal is aimed at learning what activates these cells and how their antibody responses are contributing to broad immunity to influenza. Gaining this knowledge is critical for harnessing the potential broad protective powers of this cell through vaccines and/or therapeutics.